Mitochondrial NAD+ in Acute Myeloid Leukemias

PROJECT SUMMARY
Targeting mitochondrial metabolism is an active area of research in Acute Myeloid Leukemia (AML).
The cumulative data indicate that AML cells have heightened mitochondrial activity and prefer glutamine as a
carbon source compared to noncancerous cells. Nevertheless, a challenge that emerges when trying to target
these vulnerabilities one at a time is the continued presence of treatment-refractory AML cells, which ultimately
result in relapse or developed resistance. The likely causes are the adaptable nature of metabolic pathways
and cell-to-cell variability, either due to local environment or genetics.
We propose that loss of mitochondrial nicotinamide adenine dinucleotide (NAD+) will simultaneously
block multiple metabolic pathways used by AML with minimal toxicity in healthy cells. We recently published
that the SLC25A51 transporter is a critical regulator of mitochondrial NAD+ levels in human cells. SLC25A51 is
directly responsible for NAD+ import, and modulation of SLC25A51 expression controls the concentrations of
NAD+ in the mitochondrial matrix. Loss of SLC25A51 resulted in depleted NAD+ only in mitochondria and not
throughout the whole cell. Until now, there has been no way to selectively deplete mitochondrial NAD+ through
an endogenous target. Notably, we have found a broad vulnerability across AML cells to SLC25A51 depletion,
including lines that previously were found to escape Complex I inhibition.
This proposal will determine the extent that SLC25A51 impacts AML in vivo, elucidate the pathways
that this transporter supports, and determine the molecular mechanisms controlling its expression. As there are
limited treatment options for patients, the long-term benefit of this work is to establish a rationale for targeting
mitochondrial NAD+ through SLC25A51 and to identify additional AML therapeutic approaches.

Public health relevance
PROJECT NARRATIVE With no cure for older patients afflicted with Acute Myeloid Leukemia (AML), this proposal investigates how the loss of a newly identified protein that controls mitochondrial activity will impact the disease. AML depends on the metabolic pathways in mitochondria and our hypothesis is that targeting this single regulator can simultaneously cripple multiple hallmarks of the cancer. Establishing the extent of its control is the critical first step towards being able to target this new protein as a vulnerability for AML.